Targeting DNA Repair for Cancer Therapy.

This R35 renewal application seeks to identify and exploit tumor-specific vulnerabilities based on DNA repair
deficiencies and to develop novel therapeutic strategies that specifically target tumors. In the recent funding
period, we discovered that elevated levels of the oncometabolites 2-hydroxyglutarate (2HG), fumarate, and
succinate in human cancers inhibit homology-dependent repair (HDR) by disrupting chromatin signaling at DNA
double strand breaks (DSBs), conferring a previously unsuspected vulnerability to PARP inhibitors (PARPi).
These oncometabolites are over-produced in human malignancies with mutations in isocitrate dehydrogenase-
1 and -2 (IDH1/2), fumarate hydratase (FH), and succinate dehydrogenase (SDH). Our work, published in
Nature, Nature Genetics, and Science Translational Medicine, has led to seven new clinical trials testing a new
therapeutic paradigm of treating these tumors with PARPi, with promising initial results. In this renewal, we
propose to further elucidate fundamental mechanisms underlying the DNA repair deficiency in oncometabolite-
producing cells, with a focus on chromatin remodelers and DNA end-protection factors, prompted by new data
from RNA-sequencing analyses. We will also probe potential pathways of PARPi resistance and develop
strategies to overcome them. Approaches will include comprehensive analyses of DNA repair and chromatin
regulation, unbiased CRISPR screens, and small molecule drug screens.
We have also demonstrated tumor-specific targeting by peptide-drug conjugates via a pH-sensitive peptide
(pHLIP) that exploits tumor acidity, with a pHLIP-exatecan conjugate that we developed now in a Phase 1 trial.
Based on our pre-clinical work that established specific delivery to tumors with sparing of bone marrow, we
propose to develop new pHLIP-small molecule conjugates that inhibit the DNA repair factor, DNA-PK, to
selectively radiosensitize tumors while sparing healthy tissue. We will perform tumor efficacy and normal tissue
toxicity studies with a goal of advancing a tumor-specific radiosensitizing agent for clinical translation.
We have also produced a novel version of our cell-penetrating and tumor targeting antibody (designated
V66, a humanized 3E10 variant). With this antibody, we will test a new hypothesis that we can exploit intracellular
antibody/antigen clearance pathways to develop bispecific antibodies as selective protein degraders, combining
a V66 arm (for its tumor targeting and cell penetration properties) with a second antibody arm specific for binding
to an intracellular factor. This work could provide a new class of cell-penetrating, proteolysis targeting antibodies
(PROTABs) to degrade otherwise undruggable intracellular factors for cancer therapy. Importantly, we have now
obtained key proof-of-concept data that we can achieve targeted protein degradation of GFP by treatment of
cells with a newly generated V66/anti-GFP bispecific antibody.
This work spans from foundational basic science to pre-clinical animal tumor work, with potential for clinical
translation, and so is well suited to the broader scope of the R35 funding mechanism.

Public health relevance
We seek to identify and exploit tumor-specific vulnerabilities based on DNA repair deficiencies and to develop novel therapeutic agents that can specifically target tumors. Our discovery linking mutations in metabolic genes to reduced DNA repair and consequent vulnerability to PARP inhibitors is being tested in the clinic, and we propose to further uncover the underlying mechanism, identify potential mechanisms of resistance, and determine strategies to overcome them. We have also developed novel peptide-drug conjugates and antibody- based strategies for tumor specific targeting to inhibit DNA repair and to degrade intracellular targets, respectively, and we will investigate the mechanism of action of these agents and elucidate how they can best be used for cancer therapy.